Stigma and Substance Use as Barriers to PrEP Linkage, Uptake, Adherence, and Persistence among BMSM

This application is in response to PAS-18-915 HIV/AIDS High Priority Drug Abuse Research. HIV incidence
among Black men who have sex with men (BMSM) in the southeastern United States is one of the highest in
the world. Our research team has conducted studies with BMSM in Atlanta that have demonstrated 35% HIV
prevalence and over 5% annual HIV incidence. Although PrEP is highly effective for preventing HIV
transmission, it is not reaching BMSM. The failures in our ability to engage BMSM in PrEP use are highly
problematic given the alarming rates of HIV transmission among this group. In our most recent work with
BMSM in Atlanta, we found that only 4% (n=19/474) of BMSM are currently taking PrEP even though
90% (n=428/474) are aware of PrEP. Of particular concern is the impact of substance use as a barrier in
PrEP linkage, uptake, adherence, and persistence. Substance use is common among BMSM in our study, with
43% (n=204/474) reporting recent substance use. And, critically, in our most recent longitudinal study
with BMSM, substance users were more than twice as likely than non-substance users to test HIV
positive, 7% (n=15/205) vs. 2% (n=4/244) at baseline testing, and an additional 7% (n=13/190) vs 3%
(n=8/240) at study follow up one year later. Further complicating PrEP use is the potential impact of COVID-
19 on health care access, health care infrastructure, and sex behavior. The need to better understand PrEP
use in the context of our new health care landscape is critical to making advances in PrEP use. At this point,
assessing how substance use impacts PrEP use is challenging because PrEP implementation is so low among
this group. The proposed research aims to provide substance using BMSM with evidence-based PrEP
engagement counseling to address barriers to accessing PrEP (not for intervention testing, but for
facilitating PrEP use) and to assess the multiple forms and paths of stigma and substance use as they
relate to PrEP linkage, uptake, adherence, and persistence. We propose using the HIV Stigma Framework
as a conceptual model for investigating the intersecting pathways of stigma drivers and stigma
mechanisms as they relate to PrEP use among substance using BMSM. Aim 1: Enroll a prospective cohort
of N=500 BMSM who test HIV negative and test substance use positive on toxicology testing, and provide
evidence-based PrEP engagement counseling to facilitate access to PrEP care. Aim 2: Conduct psychosocial
and health care access assessments every 2-months for 18-months, and conduct HIV/STI testing and dried
blood spot testing for TFV-DP every 3-months for 18-months. Aim 3: Using data collected from Aims 1 and 2,
model stigma pathways of advancing and reverting along the PrEP cascade (i.e., linkage, uptake, adherence,
persistence), with these pathways mediated by health care access and moderated by substance use.
Achieving the aims will provide critical insight for translating and adapting interventions to enhance potency
and durability for individuals at exceedingly elevated risk for HIV.

Public health relevance
The proposed research aims to assess the multiple forms and paths of stigma and substance use as they relate to pre-exposure prophylaxis (PrEP) use for HIV prevention. How stigma and an evolving public health landscape impact PrEP use among BMSM who use substances is unknown. The current application focuses on addressing critical and novel questions to improving the essential building blocks of biomedical prevention approaches by providing crucial information for enhancing interventions to lower HIV prevalence among substance using BMSM.